Imaging Surveillance After Lung Cancer Treatment

Project Background
Lung cancer represents a large burden of disease within the US and the VA population killing more Americans
than the top three cancer types combined. Fortunately, the widespread adoption of CT screening for lung
cancer is expected to result in more patients identified with early stage disease, however these patients still face
a significant risk of lung cancer recurrence or development of a second primary lung cancer. National
guidelines for follow up imaging surveillance exist, however structured data to evaluate guideline concordance
and associations between guideline concordance and clinical outcomes are lacking. The current literature upon
which the guidelines are based are not robust at the most recent data offer conflicting recommendations. Thus,
the goal of this study is to examine patterns of post-treatment surveillance and determine concordance with
national guidelines, impact of surveillance on clinical endpoints, and model best practices for optimal
surveillance strategies in this high risk population.
Project Objectives
The objectives of this study are to (a) determine patterns of care and concordance with national guidelines for
imaging surveillance, (b) determine the impact of guideline concordant routine imaging surveillance on clinical
endpoints, and (c) evaluate the effectiveness of newer recommendations stratified by stage and cancer
treatment on post-lung cancer treatment survival to clarify provider decision conflict.
Project Methods
To achieve these objectives, we will conduct a retrospective analysis of secondary clinical data linking patient
records from multiple data sources. Patient demographics, provider information, inpatient ICD-9 codes for
medical comorbidities, and diagnostic and treatment interventions from the Central Data Warehouse (CDW)
will be linked to mortality records in CDW and other VHA vital status files. Cancer data will be obtained from
the VA Central Cancer Registry (VACCR) including stage, treatment, and recurrence information. VACCR will
also provide initial cohort identification. Raw CDW data files will be used for radiology text report information
which are also available through CDW. To perform more efficient data collection, we will use a novel semi-
automated chart abstraction method previously employed by our team for detection and categorization of lung
nodules in an unscreened population. The method involves feeding electronic text imaging reports through a
two-step process using coded data through SQL, a search tool to identify presence of potential key words
related to each category, followed by manual chart review from highlighted text abstracts. Imaging tests will be
categorized as to the indication for a given study, the presence or absence of recurrent or new disease as well as
recommendations for follow-up. Patterns of care received will be compared to national standards to assess
concordance with published guidelines and specific radiologist recommendations for follow-up. Clinical
outcomes will be assessed to determine the association between receipt of guideline concordant care and
detection of recurrent or new lung cancer, receipt of secondary therapy or interventions, and overall and lung
cancer specific survival. We will then examine survival outcomes associated with adherence to
recommendations based on the findings of the prospective randomized controlled Intergroupe Francophone de
Cancerologie Thoracique (IFCT) group trial supporting less frequent surveillance imaging versus the newest
National Comprehensive Cancer Center clinical guidelines supporting more frequent imaging for patients with
late stage disease. Our goal in Aim 3 would be to test the impact of the newer recommendations that rely on
tailoring imaging surveillance based on stage and treatment in order to reconcile the impending conflict
between the two recommendations.

Public health relevance
Lung cancer represents a considerable disease burden within the Veteran population. It is diagnosed at a rate of 18.8%, second only to prostate cancer in highest incidence. However, even after definitive treatment, lung cancer patients remain at risk for recurrent disease and developing second primary lung cancers for which imaging surveillance guidelines exist. By examining the patterns of care, guideline concordance, and clinical outcomes associated with post-treatment surveillance following definitive treatment for lung cancer, the VA may better define the elements of quality care for lung cancer patients and enhance the ability of the healthcare system to respond to the anticipated increased imaging demands associated with the adoption of CT screening within the VA population.